Biodistribution and biological impact assessment of micro-plastics water contaminants using a sensitive and reliable Xenopus experimental platform

This research proposal addresses growing concerns about small plastic debris (0.1µm to 5 mm) or
Microplastics (MPs) that have become major pollutants of aquatic ecosystems worldwide and pose serious
threats to human health. We propose to leverage a comparative biology approach using the amphibian
Xenopus laevis to define the biodistribution of representative environmentally relevant virgin and
experimentally aged MPs; and determine how postembryonic exposure to these MPs can induce
perturbations of development, fitness, immune homeostasis, chronic inflammation, and poorer
antimicrobial immunity that are exacerbated at higher water temperature.
Our rationale to leverage X. laevis is that (1) it is a reliable, extensively characterized and widely recognized
model of human perinatal and biomedical research; (2) because the post-embryonic development of X. laevis
tadpoles is external and not protected by the maternal environment, the immune system differentiation is
particularly sensitive to perturbations by water pollutant such as MPs; (3) X. laevis wide thermotolerance is
ideal for exploring the influence of temperature on MP biodistribution and biological activity; (4) it is cost
effective to expose tadpoles in large numbers to MPs; and (5) X. laevis immune system is remarkably similar to
that of humans and we have convincingly established X. laevis as a human health relevant experimental
organism to reveal deleterious effects of developmental exposure to water pollutants.
To test the hypothesis that developmental exposure to MPs induces perturbations of development,
fitness, immune homeostasis, chronic inflammation and poorer antiviral immunity that are exacerbated
at higher water temperature, we will determine: (1) the biodistribution of environmentally-relevant virgin and
experimentally aged MPs in exposed tadpoles, by visualizing and quantifying the transit, dissemination and
accumulation of different types, doses, sizes and treatments of MPs in exposed tadpoles; (2) the effect of
water temperature on MP’s biodistribution, by comparing the changes in biodistribution and accumulation of
various MPs at different temperatures; and (3) the impacts of virgin and aged MPs on development, fitness,
immunity, and resistance to pathogens by monitoring the survival, developmental rate, success, and fitness of
tadpole exposed to virgin and aged post-consumer MPs for Ontario Lake, as well as by assessing whether
later in life young adult frogs have any defects in basal immune function or resistance to infectious diseases.
We anticipate that this innovative project will provide crucially needed evidence about biodistribution,
biological activity and health risks posed by MPs in water under current and future climate scenarios, including
exacerbated or deregulated immune function and resistance to microbial pathogens. In addition, we will identify
sensitive and reliable biomarkers useful for human studies. Given the high degree of evolutionary conservation
of vertebrate physiology, the expected outcomes from this study will be applicable and relevant to humans.

Public health relevance
Project 3 – Project Narrative Although increasing exposure to plastic debris such as microplastics have become a major concern for human health, little is still known about their specific long-term biological impacts and how climate changes affect these effects. The goal of this project is to leverage a sensitive and reliable experimental platform in the amphibian Xenopus laevis to rigorously assess the biodistribution of microplastics and resulting impacts on development, fitness, immune homeostasis and antimicrobial immunity, under varied conditions of temperature. Given the high degree of evolutionary conservation of vertebrate physiology, the outcomes from this study are relevant to human health.